FASEB SRC: The Mechanisms of Allostasis Conference: Stressed or Stressed Out

Abstract
This proposal requests partial support for a new conference entitled “Stressed or Stressed Out:
The Conference on Mechanisms of Allostasis,” a Summer Research Conference (SRC) to be
held at the Astor Crown Plaza, New Orleans Louisiana, September 18 - 21, 2022. The goal of
this conference is to bring together expert researchers at all career stages to advance our
knowledge of how allostatic load affects communication networks and signaling pathways
linking organ systems to affect various physiologic functions and disease states. The specific
aims of this meeting will be to convene approximately 150 researchers to discuss the latest
science related to stress and the fundamental mechanisms of allostasis; facilitate
interdisciplinary exchanges among experts in the fields of stress biology, neuroendocrinology,
and related disciplines; support the participation of a diverse group of trainee and junior
scientists; and deliver educational experiences for trainees that leverage the resources and
expertise of the Endocrine Society and the Federation of American Societies for Experimental
Biology (FASEB). The meeting program will include 5 sessions with speakers discussing novel
nodes of stress-reproductive neuroendocrine communication; stress and the gut microbiome-
brain axis; stress and mitochondria; programming of homeostatic mechanisms during brain
development; and central circuits controlling the autonomic nervous system and homeostasis.
A 6th session will feature short talks from graduate students and postdocs selected from
submitted abstracts. Three poster sessions will provide all participants with opportunities to
present their work. Additional educational content for graduate students and postdocs will be
provided through small-group discussion sessions during lunch. This new meeting will enable
an exploration of allostatic load in a focused way and with attention to the underlying
mechanistic details foundational to neurobiological, behavioral, and/or psychopathological
responses to adverse stressors.

Public health relevance
Narrative In the field of stress biology research, allostasis refers to mediation of the stress response through the action of hormones and other chemical messengers to maintain homeostasis with accumulation of stress-induced load on allostatic systems impacting interconnected physiological systems throughout the body, contributing to adverse health outcomes and chronic disease. The brain is central to the interpretation and control of allostatic signals and systems and also sensitive to allostatic load itself with allostatic load contributing to various neuropsychiatric disease outcomes. Stressed or Stressed Out: The Conference on Mechanisms of Allostasis: Stressed or Stressed Out will gather researchers at all career stages to discuss the latest science on stress and the fundamental mechanisms of allostasis, including the role of hormones and other mediators of allostatic load.